Advanced Computation Core

PROJECT SUMMARY
The human sense of sight involves the development and action of billions of neurons and glia to process the
signals in millions of photoreceptors. Understanding how vision works and how it fails in disease requires the
acquisition, storage and computational analysis of large datasets derived from human and animal studies, all to
be supported by this core to increase our knowledge of the visual system. The Stanford Vision Advanced
Computational Core will provide support in computer storage, high performance computing and programming,
bioinformatics, and biostatistics for vision research. A second aspect of the Core is to facilitate collaboration
through the exchange of adaptation of special purpose software and algorithms between laboratories that have
a need for computational modeling and analyses, but whose personnel lack sufficient computational expertise.